Expanding Opportunities in Genomic Research for Underrepresented Students

Abstract: This proposal seeks the renewal of the Opportunities in Genomics Research (OGR) Program. Since
2007, the OGR Program has been run out of The McDonnell Genome Institute at Washington University in Saint
Louis and funded through the NHGRI's Diversity Action Plan. The mission of the OGR Program is to increase
the representation of students from underrepresented groups in genome science or genome science-related PhD
and MD/PhD programs. We seek to accomplish our mission through the effective execution and evolution of
summer undergraduate and academic year post-baccalaureate research programs for students from racial and
ethnic backgrounds underrepresented in the sciences, students from disadvantaged backgrounds, and students
with disabilities. Both OGR programs provide trainees with cutting-edge research experiences in genome science
or related fields and 11 other educational activities that seek to train them to think critically and to write and
speak effectively about their research. Workshops and classes are tailored to train students in the core concepts
of genome science, bioinformatics, and scientific presentation. Professional development activities focus on
helping students prepare for and excel in graduate school interviews and graduate school itself.
Over its three funding cycles, student outcomes for the OGR program reveal great momentum. PhD
matriculation of students in our summer program rose from 29% in the first cycle to 50% or above the last two
cycles. More impressively, PhD matriculation of students in our post-baccalaureate program rose from 44% in
the first cycle to 75% in the second cycle and 90% in the current cycle. We expect the implementation of new
and modified activities to solidify and extend these gains. Specifically, new activities will promote integration
among OGR trainees and trainees in the NHGRI T32 PhD Genomic Sciences program, enhance training in
bioinformatics, provide trainees with greater exposure to the diversity of research careers available to PhD
scientists, and initiate community outreach events to under-served area high schools and their students.
Based on the past success and current plans of our program, we seek support for five more years of funding to
continue our mission of enhancing diversity in PhD programs nation-wide. We propose to expand our post-
baccalaureate program to five trainees per year, and with university support, to maintain the size of our summer
undergraduate program at eight students per summer. We believe our programs will continue to help realize the
great scientific and intellectual potential inherent within the diverse population of the United States, much of
which currently lies latent due to the underrepresentation of many sectors of our nation's population within
scientific research in general and genome science in particular.

Public health relevance
Narrative: The Opportunities in Genomics Research (OGR) Program is designed to increase the number of students from underrepresented groups who pursue PhDs in genome science and related fields. OGR runs a summer undergraduate research program and an academic year post-baccalaureate research program. Through a suite of educational activities, these programs seek to train students to think critically and to write and speak effectively about their research project and science in general, and ultimately prepare them to gain acceptance to and succeed in top biomedical PhD programs nationwide.